Biomechanics and strength in the distal upper limb influence median nerve health in manual wheelchair users

SUMMARY. Development of best practices to prevent carpal tunnel syndrome (CTS) among manual wheelchair
users is currently blocked by the scarceness of biomechanical analyses at the wrist. For example, despite
comparable pain and injury prevalence, there are 8-fold more scientific publications focused on the shoulder
than the wrist. To prevent CTS and preserve independence, there is a critical need to determine which patterns
of forces and joint motions utilized by manual wheelchair users in their daily life injure the median nerve. The
overall objective for this application is to establish that both the physical demands of wheelchair propulsion and
musculoskeletal capacity affect median nerve health in manual wheelchair users with SCI. Our central
hypothesis is that insufficient muscle strength, relative to the force applied by the hand to the handrim during
propulsion, causes the declines in median nerve function that ultimately lead to CTS. Our rationale is that by
establishing the balance between the physical demands of wheelchair propulsion and upper limb strength
needed to protect median nerve health, we will enable clinicians to identify asymptomatic individuals at high risk
for chronic nerve injury and to design preventative interventions that improve safety factors and decrease
cumulative risk of developing CTS, such as targeted strengthening, or optimization of wheelchair fitting. In Aim
1, we will determine if clinical measures of median nerve health are better in manual wheelchair users with SCI
who apply smaller handrim forces during propulsion. Enabled by our innovative markerless motion capture
approach, we will measure both handrim force and wrist range of motion during overground propulsion in a large-
scale (N=200), cross-sectional study. We hypothesize that people who apply smaller forces to the handrim during
propulsion have healthier median nerves, which we will quantify via clinical nerve conduction tests. We will also
test if wrist range of motion during propulsion – observable without any instrumentation on the participant or their
wheelchair using our markerless methods – predicts handrim force. In Aim 2, we will determine the balance
between handrim force and upper limb strength required to protect median nerve health. We will measure
maximum grip, isometric wrist, and isometric pronation and supination strength among our 200 participants. We
hypothesize that the ratio between handrim force and maximum grip strength increases with worse median nerve
function, and we will evaluate whether including the other strength measurements improves our model of median
nerve health. Development of personalized biomechanical models in Aim 3 will elucidate internal muscle loading
in the distal upper limb during propulsion and provide the first assessment of the role of active muscle function
in median nerve injury. Our innovative methods directly address the bottlenecks of marker-based methods that
limit data generation and clinical translation. Combined with our interdisciplinary expertise, we are poised to
collect an unprecedented amount of data, providing a new foundation needed to prevent the secondary condition
of carpal tunnel syndrome in this already over-burdened population.

Public health relevance
PROJECT NARRATIVE. The proposed research is relevant to public health because 5.5 million adults use a wheelchair, and the prevalence of carpal tunnel syndrome (CTS) in this population remains much higher than that of both the general ambulatory population and of service and production workers. Through a large-scale, cross-sectional study of manual wheelchair users with spinal cord injury, we will establish the balance between the physical demands of wheelchair propulsion and upper limb strength needed to protect median nerve health, enabling clinicians to identify asymptomatic individuals at high risk for chronic nerve injury and to design preventative interventions that improve safety factors and decrease cumulative risk of developing CTS. Prevention of secondary conditions for individuals with physical impairments and disabilities is a research priority of NCMRR, which is housed within NICHD, one of the sponsors of the Funding Opportunity Announcement to which we are responding.